Advancing Competitive Biomedical Research in Puerto Rico

Project Summary
The overall goal of the Puerto Rico IDeA Network of Biomedical Research Excellence is to augment
research capacity in Puerto Rico at the Lead and Network institutions by enhancement of the research
infrastructure, providing support for meritorious research projects and providing research experiences for
undergraduate and graduate, students, postdoctoral associates, and early career investigators. The PR-INBRE
consists of 2 research-intensive institutions, University of Puerto Rico (UPR) Medical Sciences Campus (MSC)
and UPR-Rio Piedras Campus, 7 Primarily Undergraduate Institutions (PUIs) (UPR-Cayey, UPR-Humacao,
UPR-Mayaguez, InterAmerican University Metropolitan Campus, and Universidad Ana G Mendez- Gurabo,
Carolina, and Cupey campuses), and 10 Outreach Institutions (OIs). The 17 institutions of the network serve a
total of 59,692 full-time students primarily of Hispanic ethnicity, pursuing Ph.D., M.S., and B.S. degrees in
STEM and biomedical disciplines. The UPR-MSC is the Lead institution of the PR-INBRE. The PR-INBRE
consists of an Administrative Core at the UPR-MSC that provides administrative support and scientific
assessment to the network, a Bioinformatics Resources Core (BiRC), a Centralized Research Instrumentation
Core (CRI), a Science, Technology, Competency and Education Core (STCE), and a Developmental Research
Projects Program (DRPP). The PR-INBRE network has made great strides in the development of the research
enterprise at several network institutions during the current funding period (2015-2020). In the next cycle, we
will continue to enhance professional growth of PUI early career stage faculty and we will place greater
emphasis on training of postdoctoral associates through not only financial support of meritorious research
proposals from this group but also increased professional exposure and networking opportunities outside of
Puerto Rico. This would be accomplished through seminar presentations co-sponsored by other INBREs, and
improvement of the quality of their research proposals through sustained grant-writing workshops for R15 and
R21 proposals and editorial support. Scientific infrastructure and instrumentation at PUIs will also continue to
be upgraded every year through a PR-INBRE small instrumentation program for teaching and research labs. In
the next cycle, student support will continue to be a top priority of the PR-INBRE through research experiences
in funded laboratories and mentoring with the goal of directing them to seek graduate studies and Postdoctoral
positions in biomedicine. Overall, the improvements to the institutional environment of the network PUIs to date
can be associated with increased research capacity as measured by the number of successful high-quality
research proposals submitted to external federal and non-federal funding sources, and published manuscripts
in peer-reviewed journals by the PR-INBRE PUI investigators. Continuation of this valuable and essential
support for the next cycle is well justified to sustain the continuous growth and maturation of this thriving
INBRE network in Puerto Rico.

Public health relevance
PROJECT NARRATIVE The Puerto Rico IDeA Networks of Biomedical Research Excellence (PR-INBRE) will create new opportunities to study health disparities, develop novel treatments for human diseases, and explore fundamental research questions in the thematic focus areas of Bioinformatics, Neuroscience/Behavior, Molecular Medicine/Cancer, Drug Discovery and Development. By enhancing the biomedical research enterprise in Puerto Rico, the PR-INBRE will increase the representation of Hispanics in the national biomedical workforce and expand their contributions to the improvement of human health.